Eunice Kennedy Shriver NICHD Maternal-Fetal Medicine Units (MFMU) Network

The Division of Maternal-Fetal Medicine at Brown University/Women & Infants Hospital of Rhode Island (WIH),
along with our Yale University site, has a strong commitment to a continued high-level of participation in the
Eunice Kennedy Shriver NICHD Maternal Fetal Medicine Units (MFMU) Network for the purpose of completing
the ongoing Network trials and ongoing or planned registries. The focus of these trials and registries is
understanding and ameliorating the pernicious problems of prematurity (and its sequelae) and maternal
morbidity and mortality. We have extensive experience in performing clinical trials and observational studies in
these areas, are recruiting for all of the ongoing protocols, and have a strong, stable, and proven research
infrastructure. We have been a participating center for the past four 5-year cycles of the MFMU Network and
the addition of our Yale site has only augmented our capabilities, adding some 5,500 deliveries to WIH’s
~9,000 deliveries. We remain well positioned to be a productive contributor to the Network and will continue to
bring our experienced, competent, and enthusiastic research team to bear on the ongoing protocols with the
goal of helping the MFMU Network reach its fullest potential.

Public health relevance
PROJECT NARRATIVE The Division of Maternal-Fetal Medicine at Brown University/Women and Infants Hospital of Rhode Island (WIH), as well as our Yale University site, will continue our high-level of participation in the Eunice Kennedy Shriver NICHD MFMU Network. In doing so, we will work toward finding solutions to the problems such as prematurity and maternal morbidity and mortality being addressed by the Network’s ongoing trials and ongoing or planned registries.